CHERP Cancer Research Education Program

CSUF/UCI-CFCCC Cancer Health Equity Research Partnership (CHERP)
Cancer Research Education Program (CREP): Abstract
The long-term goal of the Cancer-Related Education Program (CREP) is to increase the diversity of the cancer
research workforce by training undergraduate and master’s graduate students in cancer health disparities-
related research efforts, especially those from underrepresented groups. This objective will be accomplished
through providing education in the cancer health disparities field, including established facts as well as the
newest research exploring the interrelationships of biological components, socioeconomic factors, cultural
aspects, nutrition, stress, and the environment that result in certain groups bearing a disproportionate burden
of cancer. A profound understanding of the biological bases of cancer as well as of cancer disparities aspects
such as differences in incidence, prevalence, morbidity and mortality, quality of life while on treatment, length
of survivorship, and access to diagnosis will inspire students to pursue research career on these topics and
result in a highly diverse pool of highly talented future scientists from different backgrounds. The proposed
CSUF/UCI-CFCCC partnership is particularly suited for this goal because of our ethnically diverse student
populations and the high number of students from low socioeconomic backgrounds. CREP will consist of a 5-
term (undergraduates) or 3-term (graduates) path that will provide a comprehensive education. The specific
aims of the CREP are to: 1. Develop coursework paths and research experiences focused on cancer disparities
and other cancer topics; 2. Create synergistic educational components such as community building activities
and travel to research conferences; and 3. Establish outreach opportunities that help prepare CREP students
to succeed in transitioning to higher degree programs and inform faculty and students outside of the program
about the need to research and mitigate cancer health disparities. To accomplish these aims, we will undertake
a robust association between the two institutions. The educational paths will include instruction in basic
concepts and the newest research on cancer and cancer disparities. CREP scholars will also experience
summer research training in a laboratory of their choice within a rich list of opportunities at CSUF or UCI. In
addition to the documented benefits of supplemental coursework and research training, CREP students will
benefit from opportunities and experiences, offering them a variety of identity and community building activities
as well as travel to research conferences. Several outreach activities will be organized at CSUF and UCI to
disseminate information about the program and the importance of cancer research and cancer disparities. The
evaluation will capture the number of students progressing through these activities, monitor their progress and
relationships with faculty mentors, and track their future careers. CREP activities will increase the pool of
talented underrepresented students who enter the cancer-related research workforce in the future.
.

Public health relevance
CSUF/UCI-CFCCC Cancer Health Equity Research Partnership (CHERP) Cancer Research Education Program (CREP): Narrative The Cancer-Related Education Program (CREP) will contribute to the enhancement of cancer health equity in Southern California. CREP will promote an increase in the diversity of the cancer research workforce by training undergraduate and master’s graduate students in cancer health disparities-related research efforts, especially those from underrepresented groups. CREP will provide cancer and cancer health disparities education to undergraduate and master’s students. CREP will also include several outreach activities at CSUF and UCI to disseminate information about the program and the importance of cancer research and cancer disparities. .